Loss of Matrix Regulation and Aortic Aneurysm Development in vivo

Project Summary Defects in synthesis/assembly of vascular extracellular matrix (ECM) or accelerated degradation of ECM are known causes of aortic aneurysms. ECM also serves as an external regulator of growth factor-mediated signaling by sequestering and fine-tuning the level of available ligands. In addition, ECM has profound effects on smooth muscle cell (SMC) phenotypes and mutations in SMC contractile proteins have been shown to be responsible for subsets of thoracic aortic aneurysms in humans. Fibulin-4 (Fbln4) is a secreted glycoprotein expressed in large blood vessels and essential for formation of elastic fibers in vivo. Fbln4 deficiency in mouse and humans results in cutis laxa and aortic aneurysms with severe disruption of elastic fibers. We recently generated mice carrying conditional knockout alleles of Fbln4 and showed that lack of Fbln4 in SMCs (Fbln4SMKO) leads to aortic aneurysms exclusively in the ascending aorta by 3-months of age. Fbln4SMKO aortae develop abnormal elastin and collagen fibers and a focal thickening of the aortic wall with proliferation of SMCs, downregulation of terminal SMC differentiation markers and a marked increase in phosphorylated (p-)ERK1/2 levels. In our preliminary studies, we show that the angiotensin II type 1 receptor (AT1R) blocker losartan effectively prevents aortic aneurysms with downregulation of p-ERK1/2 levels. This observation led us to hypothesize that fibulin-4 deficiency contributes to aneurysm formation through dysregulated angiotensin II (AngII) signaling in SMCs. In this application, we propose to investigate the underlying mechanism of AngII-AT1R activation in the vessel wall of Fbln4SMKO mice. We will address how altered ECM, SMC phenotype and AngII-AT1R signaling influence each other in the development of aortic aneurysms and how to obviate this process by pharmacological interventions. To test our hypothesis, our specific aims are as follows: 1) To determine if dysregulated Ang II- AT1R-mediated signaling plays a central role in aneurysm development in the Fbln4SMKO aorta, 2) To investigate the mechanism(s) of activation of Ang II-AT1R signaling pathway in Fbln4-deficient aorta, and 3) To investigate the mechanism by which abnormal SMCs and ECM contribute to aneurysm formation in Fbln4SMKO mice. Understanding the dynamic relationship between ECM and SMCs will provide a solid foundation for pharmacological interventions and could offer new therapeutic opportunities to various congenital aortic aneurysms. .

Public health relevance
PROJECT NARRATIVE This proposal focuses on a protein called fibulin-4 produced by vascular cells, which is essential for the development of a healthy vessel wall. We will study how this protein functions to prevent the development of aortic aneurysms.